SINGLE CRYSTAL EPR OF COBALT PORPHYRINS

New software written to drive pulsed EPR and cw spectrometers and for data acquisition. New software also written for data acquisition and processing for Varian E line spectrometer. This software is for modern PC operation using a Windows format and is available and transportable to other laboratories.